Rare Airway Cell Function in Post-Viral Chronic Inflammation

PROJECT SUMMARY
The airway epithelium serves as a barrier between the aerosol environment and the underlying
submucosa. Inhaled air often carries noxious agents and pathogens that can injure the lung. Severe lung injury
can lead to persistent inflammation, dysplastic repair, and permanent loss of gas exchange surface area. Injury
from common respiratory viral infection, such as influenza and SARS-CoV-2, can lead to chronic lung disease
or exacerbation of lung conditions. Airway cells contribute to regeneration following lung injury, although the
heterogeneity of airway cell identity following lung repair is incompletely understood.
My research centers on rare airway cell types and their function in the post-viral lung. We have
previously studied the differentiation of an unexpected airway cell type, tuft cells, during repair. Using single
nucleus expression and accessible chromatin sequencing to survey airway cells following influenza injury, we
identify a rare airway cell present in the post-viral lung, Microfold (M) cells. M cells have not been studied in the
lung but in other contexts associate with lymphoid follicles, where they function to capture and deliver luminal
antigens and secrete chemokines. The proposed research will identify pulmonary M cell progenitors and
determine mechanisms required for M cell differentiation. This proposal uncovers M cells as part of a follicle
associated epithelium (FAE) overlying induced bronchus associated lymphoid tissue (iBALT), implying M cells
function to promote mucosal immune responses. The proposed aims will define the role of M cells in lung
immune surveillance. My future research program will test the role of M cells in secondary bacterial infection,
as much of the morbidity of pulmonary influenza infections can be attributed to secondary bacterial infection.
Examining interactions between M cells and the immune compartment will contribute to our understanding of
immune regulation during post-viral chronic inflammation.
A second outcome from my focus on airway repair following severe influenza infection is an effort to
promote the resolution of basal-like scar tissue into normal alveolar epithelium. Bronchiolization of the distal
airway is a hallmark of multiple human lung diseases, and providing regenerative therapies will require detailed
understanding of the regulation of basal-like cells. I propose defining a genetic mouse model that promotes
differentiation of alveolar basal-like cells into alveolar epithelial cell fates.
My primary mentor is Dr. Xin Sun, a leader in the field of lung biology who has made fundamental
discoveries in lung development and disease. I will receive guidance from my mentorship committee, a group
with expertise in lung biology and physiology, immunology and epigenetics. The proposed experiments and
training plan will further my skills in bioinformatics and immunology. This research will be conducted at
University of California San Diego, a leading research institution with necessary resources and a collaborative
scientific community.

Public health relevance
PROJECT NARRATIVE Common viral respiratory infections, such as influenza and SARS-CoV-2, contribute to chronic lung disease. Following viral infection, airway repair mechanisms lead to differentiation of unexpected airway cell types within the lung, Microfold (M) and basal-like cells. This proposal will investigate the function of rare airway cell types during post-viral injury repair.